Interrogation of TLR2 Inflammatory Signaling in AML

PROJECT SUMMARY
Acute myeloid leukemia (AML) is defined as a clonal expansion of abnormal myeloid blasts which are
impaired to differentiate into mature and functional myeloid cells. Toll-like receptors (TLRs) are pathogen-
associated molecular pattern (PAMP) receptors that specialize in recognizing foreign pathogens and elicit an
innate immune response through promoting myeloid cell differentiation and inflammatory cytokine production.
The role of TLR signaling in AML is poorly understood, and the mechanisms involved in an innate immune
response through TLRs, and whether this induces differentiation and/or cell death of AML blasts is unclear. Two
of the most commonly mutated genes in AML are FLT3 and DNMT3A, where 20% of AML patients can be found
with co-occurring mutations, which results in a poor prognosis. Preliminary data indicate that TLRs are expressed
on the surface of AML cells, and stimulation of these receptors produces a proinflammatory response associated
with AML blast differentiation. In sum, I identify, in DNMT3A-mutant AML, a TLR signaling network that regulates
differentiation of AML and increases the survival of this common and clinically poor AML subtype which can lead
to a prospectively new differentiating/therapeutic agent for AML treatment.

Public health relevance
PROJECT NARRATIVE A major therapeutic goal in acute myeloid leukemia (AML) is to promote differentiation of immature blast cells to a more mature cell state that would cause AML cells to lose proliferative and self-renewal capacity and be eliminated. Preliminary data uncover a novel approach to induce differentiation of Dnmt3a/Flt3-mutant AML both in vitro and in vivo. This proposed study will fully elucidate the phenotypic and signaling consequences of TLR2 activation on DNMT3A-mutant AML and provide the first single cell map of innate immune signaling in AML cells which will reveal genes and/or pathways that can be leveraged therapeutically for AML treatment.